Training the Next Generation of Researchers in Cancer Nanotechnology at the NCI M

DESCRIPTION (provided by applicant): We propose to establish a Midwest Cancer Nanotechnology Training Center (M-CNTC) at UIUC in collaboration with regional clinical collaborators. The goal of this M-CNTC will be to produce the next generation of intellectual leaders who will define the new frontiers and applications of nanotechnology in cancer research. This goal would be accomplished by creating a highly interdisciplinary environment which educates and empowers the students and post-doctoral fellows in the training center to take leadership roles and address the challenges at the cross-roads of cancer biology, physical sciences, and nanotechnology. It is known that more than a 1.5 million people were diagnosed with cancer and half a million died of cancer in US alone during 2007. In spite of a considerable effort, there has been limited success in reducing per capita deaths from cancer since 1950. This calls for a paradigm shift in the understanding, detection and intervention of the evolution of cancer from a single cell to tumor scale. In this M-CNTC proposal, we have responded to this very timely need and assembled a preeminent interdisciplinary team of researchers and educators across UIUC and clinical collaborators in the region from University of Illinois at Chicago, Mayo Clinic, Indiana University School of Medicine, and Washington University at St. Louis, to train the next generation of engineers, physical sciences, and biologists to address the challenge of understanding, managing, diagnosing, and treatment of cancer using the most recent advancements in nanotechnology. The proposed program represents a highly coordinated and interdisciplinary effort to educate scientists and engineers across UIUC and clinical partner institutions to tackle the important problems in applications of nanotechnology to cancer research. Taking advantage of the expertise in nanofabrication, imaging, nano-materials, and cancer biology in our team, the program is expected to significantly impact quantitative methods used in cancer research. Our unique educational training components will not only transform graduate education on our campus, but also to be an empirically validated model for other programs in this area.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to establish a Midwest Cancer Nanotechnology Training Center (M-CNTC) at UIUC in collaboration with regional clinical collaborators. The goal of this M-CNTC will be to produce the next generation of intellectual leaders who will define the new frontiers and applications of nanotechnology in cancer research. Principal Investigator/Program Director (Last, First, Middle): Bashir, Rashid Narrative We propose to establish a Midwest Cancer Nanotechnology Training Center (M-CNTC) at UIUC in collaboration with regional clinical collaborators. The goal of this M-CNTC will be to produce the next generation of intellectual leaders who will define the new frontiers and applications of nanotechnology in cancer research. PHS 398/2590 (Rev. 09/04) Page Continuation Format Page __SpecificAimsTextDelimiter__ Principal Investigator/Program Director (Last, First, Middle): Bashir, Rashid Training the Next Generation of Researchers in Cancer Nanotechnology at the NCI Midwest Cancer Nanotechnology Training Center: M-CNTC 2. Specific Aims We propose to establish a Midwest Cancer Nanotechnology Training Center (M-CNTC) at UIUC in collaboration with regional clinical collaborators. The goal of this M-CNTC will be to produce the next generation of intellectual leaders who will define the new frontiers and applications of nanotechnology in cancer research. This goal would be accomplished by creating a highly interdisciplinary environment which educates and empowers the students and post-doctoral fellows in the training center to take leadership roles and address the challenges at the cross-roads of cancer biology, physical sciences, and nanotechnology. It is known that more than a 1.5 million people were diagnosed with cancer and half a million died of cancer in US alone during 2007 (Cancer Statistics 2007, ACS). In spite of a considerable effort, there has been limited success in reducing per capita deaths from cancer since 1950. This calls for a paradigm shift in the understanding, detection and intervention of the evolution of cancer from a single cell to tumor scale. In this M-CNTC proposal, we have responded to this very timely need and assembled a preeminent interdisciplinary team of researchers and educators across UIUC and clinical collaborators in the region from University of Illinois at Chicago, Mayo Clinic, Indiana University School of Medicine, and Washington University at St. Louis, to train the next generation of engineers, physical sciences, and biologists to address the challenge of understanding, managing, diagnosing, and treatment of cancer using the most recent advancements in nanotechnology. Our broad specific aims are as follows; Specific Aim 1: Our scientific educational goals are to foster cultural change in the current educational environment via four intellectual themes in Cancer Nanotechnology: (a) early detection of pre-metastatic state of cancer cells via targeted delivery of novel polymer and metal nano-particles for imaging and in-vivo diagnostics, (b) performing ex-vivo biochip-based detection of shed DNA, cancer proteins, and markers from serum, (c) nanoparticle based therapeutic interventions, and (d) exploring the intersection of nanotechnology and mechano-biology for understanding metastatic processes. Animal models for in-vivo applications and human samples for ex-vivo diagnostics will provide the linkages to clinical and translational applications. Specific Aim 2: Our educational goals are to implement, evaluate, and disseminate a highly effective, interdisciplinary training program in cancer nanotechnology that improves upon traditional models of graduate and post-graduate education. We will; (a) develop a two week long summer school with hands-on laboratory modules in cancer nanotechnology, (b) develop a two track curriculum that provides both engineering and biology students a path to seamlessly integrate cancer nanotechnology courses and research in their PhD program, (c) infuse critical thinking, leadership, communication, team building, ethics training, and other essential topics into the program in meaningful and innovative ways; (d) effectively deploy strategies to recruit and retain a diverse set of M-CNTC pre-doctoral and post-doctoral fellows; (e) establish a trainee leadership council that plays an integral role in the strategic directions of the M-CNTC; (f) offer clinical experiences and opportunities to the trainees at regional collaborator sites; (g) develop a post-doctoral mentoring program for their scientific and professional career development, and (h) embed assessment of the training program to evaluate the added value of the M-CNTC training experience in terms of content knowledge, research skills, leadership building, and employment outcomes. Specific Aim 3: Our outreach and dissemination goals are to broaden the impact of the M-CNTC by permeating the training aspects to the broader NCI Alliance on Cancer Nanotechnology and the broader scientific and public community. We will; (a) partner with world class regional cancer centers for educating the public on the merits of nanotechnology for cancer research, (b) host an annual regional conference that brings together experts in nanotechnology and cancer researchers and the general public, and (c) partner with the NSF Network for Computational Nanotechnology to electronically disseminate the lectures and short courses. The proposed program represents a highly coordinated and interdisciplinary effort to educate scientists and engineers across UIUC and clinical partner institutions to tackle the important problems in applications of nanotechnology to cancer research. Taking advantage of the expertise in nanofabrication, imaging, nano- materials, and cancer biology in our team, the program is expected to significantly impact quantitative methods used in cancer research. Our unique educational training components will not only transform graduate education on our campus, but also to be an empirically validated model for other programs in this area. 193.9 185.8 90 04 Figure 1: Cancer deaths/100,000 in USA. (ACS 2007) PHS 398/2590 (Rev. 09/04) Page Continuation Format Page